Identification of genetic pathways that regulate kidney cell fate: Hand2 inhibits intermediate mesoderm development

PROJECT SUMMARY
The Principal Investigator seeks mentored training to investigate the genetic regulation of early kidney
development using the zebrafish embryo. Research and training will be carried out in the laboratory of Dr.
Deborah Yelon, with the support of the Division of Pediatric Nephrology at the University of California, San
Diego and an advisory committee composed of specialists in kidney development and disease and in the
genetic regulation of organ formation. The objective is to obtain training and pursue laboratory research that
will lead to the Principal Investigator's development into an independent physician-scientist. The overall goal of
the research is to elucidate the genetic pathways regulating early stages of kidney development in order to
gain insight into the etiology of kidney birth defects and to instruct strategies in regenerative medicine. To do
so, the PI will take advantage of the genetic and embryological benefits of using the zebrafish as a model
organism. Like mammalian kidneys, zebrafish kidneys are derived from the intermediate mesoderm (IM). Work
in multiple organisms, including zebrafish, has defined several conserved factors that promote IM formation.
However, the mechanisms defining the boundaries that distinguish the IM from its neighboring territories are
not yet understood. Recent studies by the PI suggest that the bHLH transcription factor Hand2 defines the
lateral border of the IM by regulating cell fate decisions within the posterior mesoderm. While the IM and
embryonic kidney are expanded in hand2 mutants, hand2 overexpression results in strong inhibition of IM and
kidney development. Additionally, hand2 is expressed in a portion of the posterior mesoderm that lies laterally
adjacent to the IM. Venous progenitors arise between these two territories, and hand2 promotes venous
progenitor development while inhibiting IM formation at this interface. The lateral hand2-expressing territory
also expresses osr1, a zinc-finger transcription factor previously implicated in promoting kidney formation, and
genetic analyses suggest that hand2 and osr1 have functionally antagonistic roles during kidney development.
Together, these data shed light on a previously unrecognized genetic network that regulates IM boundaries,
suggesting a model in which hand2 functions in opposition to osr1 to control the allocation of progenitor cells to
kidney and vein lineages. To test this model, two specific aims will be pursued. The first aim will define the role
of hand2 in the inhibition of IM lineage specification, using high-resolution fate map analysis and cell autonomy
studies. The second aim will identify genes in the pathways through which hand2 and osr1 control IM
specification, using complementary candidate gene and whole transcriptome approaches to identify relevant
partner and effector genes. These studies will elucidate the role of hand2 in IM formation and illuminate the
pathways that define the boundaries of the IM by balancing formation of the kidney and vein lineages. Over the
long term, detailed comprehension of these genetic pathways should improve diagnostic, prognostic, and
therapeutic options for patients with kidney disease.

Public health relevance
PROJECT NARRATIVE Kidney and urinary tract birth defects are the most common cause of chronic kidney failure in children, and they can increase an individual's risk for high blood pressure or urinary tract infections. A better comprehension of the mechanisms controlling the initial steps of kidney development is likely to illuminate the causes of kidney birth defects and should improve our diagnostic, prognostic and therapeutic options.